Biorepository/Pathology Core

BIOREPOSITORY/ PATHOLOGY CORE: PROJECT SUMMARY
The Biorepository/Pathology Core will collect and distribute clinically annotated human biospecimens related to
ovarian cancer and will provide pathologic expertise and support for tissue-based analyses for investigators in
the Johns Hopkins-University of Pennsylvania (UPENN) Ovarian Cancer SPORE. The main resource and
operation of this Core will be based on the current Gynecologic Cancer Biorepository (GCB) Bank that has
been a co-joint operation among the JHU Oncology Center, the Kelly Gynecologic Oncology Service in the
Department of Gynecology and Obstetrics, and the Division of Gynecologic Pathology. The GCB bank was
established in 2000 and expanded through the support of a US DoD-sponsored program project and
subsequently by the DoD-sponsored Ovarian Cancer Consortium Program. In addition, the Cellular Therapy
Tissue Facility (CTTF) at UPENN will provide all tissue procurement and processing for Project 3 (at UPENN)
and will procure and process tissue to support Projects 1 and 4 at JHU. The CTTF collects and processes
fresh tumor tissue acquired directly from the operating rooms at the Hospital of the University of Pennsylvania
and Pennsylvania Hospital, as well as from external institutions, including Chester County Hospital. Tissue will
be shared between JHU and UPENN, as well with other collaborating institutions. Thus, the Ovarian Cancer
SPORE Biorepository/Pathology Core will incorporate and build on a pre-existing infrastructure. In the last few
years, the Repository has been expanded to include expert diagnostic pathology and molecular pathology
consultation to investigators, including guidance for quantitative digital image analyses-guided molecular
studies of tissues. Specimens are collected under the supervision of pathologists with expertise in gynecologic
pathology, in close collaboration with gynecologic oncology surgical colleagues. Clinical information for
subjects enrolled in our clinical protocols is entered into a password-protected web-based tracking system,
which follows the recommendations of the National Research Council. A review mechanism is in place for
prioritization of distribution of requested resources to investigators within and external to this Ovarian Cancer
SPORE.

Public health relevance
BIOREPOSITORY/ PATHOLOGY CORE: NARRATIVE Despite many novel therapeutic and preventive strategies, ovarian cancer remains the most lethal gynecological neoplasm of women. This core resource will support projects of this application related to the detection and treatment of ovarian cancer with high-quality tissues and biosamples as well as to provide pathologic and immunologic expertise.